Community Engagement Core

The Morehouse School of Medicine’s (MSM) Center for Translational Research in Health
Disparities (CTRHD) Community Engagement Core (CEC) has advanced the mission of the RCMI
and MSM by supporting the development of minority researchers, enhancing capacity in
biomedical and behavioral research, and disseminating timely research and health information to
communities. The goal of the CTRD is to leverage our established relationships with community-
based organizations (CBOs) to enhance the infrastructure needed to conduct health disparities
research and continue to engage communities in the effort to promote health equity and identify
the health priorities of the community. To meet this goal, the CEC will address the following
specific aims: SA1: Foster sustainable community partnerships by solidifying and increasing the
numbers of CBOs, local health departments, community leaders/advocates and community-
engaged researchers to support activities that increase health equity; SA2: Expand the Multiple
Disciplinary Translational Team (MDTT) approach to disseminate health information and research
findings to diverse community stakeholders across GA; and SA3: Enhance leveraged MSM
expertise to support, build capacity for and in our underserved communities through MSM
research activities. Expanding the inclusion, engagement, capacity, breadth, and depth of
community partners and the MDTT approach are major themes of the CTRHD CEC. The CEC
will expand its reach through an innovative network of CBOs and disseminate research activities
and engage in research education to those communities served.